Administrative Core

Project Description/Abstract - Administrative Core The Administrative Core will coordinate all scientific, administrative and external reporting activities of the CEMBA research program. The central objective of the Core is to facilitate reaching the milestones of discovery laid out in the CEMBA Research Segments, Data Core and Overall program research strategies. The Center Directors and the Scientific Leadership Committee will be the ultimate decision-making body for all CEMBA administrative and scientific policies. The Core will support a Program Manager as key personnel for overseeing all Center activities, and an administrative assistant for help in meeting planning and the generation of manuscripts and progress reports. The Core will coordinate bi-weekly CEMBA research team meetings, monthly leadership committee conference calls and the annual CEMBA retreat. The administrative core will also serve as the central conduit for interaction between CEMBA and the overall BICC Network. These activities include oversight of data sharing between the CEMBA-DC and the BCDC, participation of CEMBA investigators in BICCN conference calls and working groups, attendance of team members at BICCN in-person meetings, and the development of reports, websites and other outreach activities as an integral part of the BICCN.